Recombinational Mechanisms of DNA Repair

Project Summary
Homologous recombination (HR) maintains genomic stability through high-fidelity repair of DNA double-
stranded breaks (DSB) and other complex DNA damage that is induced directly or indirectly by common anti-
tumor agents including ionizing radiation, topoisomerase-targeted drugs, interstrand crosslinking agents, and
those causing replication forks stalling. HR defects bear dual significance for cancer by first leading to genomic
instability and increased cancer predisposition. Moreover, HR defects cause specific cellular vulnerabilities that
can be exploited therapeutically either by traditional DNA damage-based treatment or by targeted treatment for
example by poly(ADP-ribose) polymerase inhibition. The overarching goal is to elucidate the mechanisms of
HR. This application focuses on a central HR intermediate, the displacement loop (D-loop), which represents
the branchpoint for the HR sub-pathways. The Specific Aims are: (1) Define D-loop length in cells and the role
of Rdh54 in D-loop metabolism. (2) Delineate the role of human RAD54B in HR. (3) Determine the roles of
RECQ1 and RECQ5 in D-loop editing and crossover control. All aims require the use of the requested
refrigerated incubator/shaker used for protein production by insect cells in this application.

Public health relevance
Project Narrative Homologous recombination maintains genomic stability by providing high-fidelity repair of DNA double- stranded breaks and other types of complex DNA damage such as interstrand crosslinks. This DNA repair pathway has dual significance for cancer as genetic defects in recombination increase cancer predisposition and as the types of DNA damages it targets are induced by common DNA damage-inducing modalities in cancer treatment. The proposed work will contribute to an improved mechanistic understanding of recombinational DNA repair, which will also benefit novel personalized treatment approaches targeting recombination-deficient tumors.